Investigating the genetic basis of human skeletal facial morphology

PROJECT SUMMARY/ABSTRACT
The human face consists of unique structures that form our identity. We have strong evidence that human
craniofacial variation has a high genetic component, influenced by ancestry and sex. The effort to improve our
understanding of ‘normal-range’ facial variation has been of great interest in the last decade as it has particular
implications for understanding the etiology of malformations in the face related to disease. Recently, an
advancement in phenotyping towards the use of quasi-landmarks applied to 3D facial scans has enriched our
knowledge with new genetic links tied to the human face. However, these and other genetic signals may
potentially be clouded by not knowing facial skeletal information underneath the skin. A complete examination
of human facial structure would be to inspect both the outer soft tissue structure and the inner hard tissue bone
concurrently, including the depth of tissue in their connection. From our ever-expanding list of craniofacial
candidate variants/genes, it is more important than ever to accurately classify their specific contribution to the
face’s development through accurate landmark placement, and correction of competing structures within the
facial construct. By doing this, we effectively provide a more precise classification of the facial link, whether it is
directed towards tissue or bone variation. This more explicit definition will allow a more efficient examination of
how these variants work in tandem for downstream gene expression and functional analyses work. This insight
would also pave the way for more accurate personalized therapeutic interventions for craniofacial treatment and
surgery, not to mention a more complete face visual for diagnostics. The current proposal has two aims designed
to significantly advance our current understanding of normal-range human craniofacial variation: (1) We will
enhance current mesh landmarking procedures by building a dense (thousands) map of vertices across the
human skeletal bone, effectively generating a craniofacial skeletal mask using quasi-landmarks, which has not
yet been made available in the field. This template will allow efficient normalized landmarking of craniofacial
bone using MeshMonk registration; (2) Utilizing a new collection of Cone Beam Computed Tomography facial
scans (n=750), allows us to connect both soft tissue with hard tissue landmarks ensuring one is a covariate
against the other facial structure being examined and perform association testing with a list of over 350 facial
candidate variants/genes. This more precise method of phenotype:genotype association has not yet been
characterized in such a manner, correcting bone from soft tissue and vice versa. For the first time, we shall also
generate Facial Soft Tissue Thickness (FSTT) at quasi-landmarks by utilizing the information gleaned from these
two structural entities and their connection in space. This project aims to confirm, with genetic association, a
more complete methodology for concurrent facial landmarking of all structures in the human face, both externally
and internally, and complement with visuals that explain the additive genetic effects of some of the currently
most interesting variants/genes discovered for human facial variation.

Public health relevance
NARRATIVE The success of testing phenotype:genotype relationships relies on encapsulating the most accurate phenotype possible, to truly measure genetic influence. This current proposal seeks to fully capture the 3D structure of the human face, both inside and out, as the technical ability to measure soft tissue structure, facial bone structure and facial soft tissue thickness in tandem, ensure the most complete facial phenotype possible. Combined with measuring the genetic influence of known craniofacial variants/genes, this study has significant implications on future normal and atypical (disease-related) craniofacial research.